Smoking Cessation Intervention for American Indian Women Experiencing Intimate Partner Violence

Cigarette smoking and intimate partner violence (IPV) are preventable, major public health concerns that result
in severe physical and psychological consequences. Women who have experienced IPV are more likely to suffer
from substance use, depression, anxiety, and post-traumatic stress disorder --all of which are risk factors for
smoking. Smoking prevalence among women who have experienced IPV is as high as 51% to 70%. American
Indian women, including Northern Plains Tribal women, experience the highest proportion of IPV among women
from any racial/ethnic group. Furthermore, smoking prevalence among Northern Plains Tribal women is among
the highest in the U.S and specifically among Northern Plains Tribal women who experienced IPV, 58% are
current smokers. Multiple health interventions have been developed for women who have experienced IPV,
including for alcohol and drug use given the high rates of these co-occurring problems. However, there have
been no smoking cessation interventions among them. Trauma-informed, mindfulness-based approaches are
shown to create physical, psychological, and emotional safety while mitigating habitual patterns of reactive or
addictive behaviors by increasing awareness of reactivity and automated (e.g., smoking) behavior, allowing
greater flexibility in response to cravings. These strength-based approaches are consistent with the values of
American Indian culture and create opportunities for individuals who have been traumatized to rebuild a sense
of choice and control. Our research team used an interactive, highly participatory approach to collect and use
qualitative data to inform the initial development of a culturally tailored, trauma-informed smoking cessation
intervention for Northern Plains Tribal women who have experienced IPV. Therefore, the primary objective of
this application is to finalize the 8-session novel intervention and test its feasibility, acceptability, and satisfaction
among a group of 48 Northern Plains Tribal women smokers who have experienced IPV. To achieve this goal,
the following Aims will be addressed: 1) Use a community-based participatory approach with our Community
Advisory Board to refine intervention materials and finalize our pilot intervention methodology; 2) Conduct a
single arm intervention trial enrolling 48 Northern Plains Tribal women smokers who have experienced IPV to
examine the primary study outcomes of feasibility, acceptability, and satisfaction with our culturally tailored,
trauma-informed mindfulness smoking cessation intervention and the secondary study outcome of quit attempts
and biochemically verified smoking abstinence prevalence at 3 and 6-months follow-up, which will gauge the
effectiveness of the intervention; and 3) As an exploratory aim, we will explore concurrent changes in drug and
alcohol use given the proposed intervention’s central focus on personal and historical trauma among American
Indian women as contributors to addiction and consistent with a focus on poly- vs. single substance.

Public health relevance
Using a highly participatory approach, this study will assess the feasibility, acceptability, and satisfaction with a culturally tailored, trauma-informed smoking cessation intervention for Northern Plains Tribal women who have experienced intimate partner violence. If successful, other American Indian Tribes and Tribal communities can adapt this innovative smoking cessation curriculum for their communities.